URINARY VASOPRESSIN IN HEALTHY AND SICK NEWBORN INFANTS

Urinary vasopressin (VP) levels are measured in healthy and sick newborns with various clinical conditions to determine the role of VP in neonatal water homeostasis.